BIOCHEMICAL BASIS OF T CELL ACTIVATION

Engagement of the multicomponent antigen receptor in T cells (TCR) results in rapid activation of a protein tyrosine kinase pathway. A major TCR- associated protein tyrosine kinase is ZAP-70, a protein that binds to the activated TCR. Under conditions of TCR activation, the ZAP-70 bound to the TCR is itself tyrosine phosphorylated and activated. We have expressed this enzyme using a baculovirus system and have developed a purification scheme enabling us to obtain sufficient ZAP-70 for enzymatic analysis. Our studies of the mechanism of ZAP-70 activation includes further analysis of mutants of the enzyme that lack critical tyrosine residues. Expression of these mutants in T cells that lack endogenous ZAP-70 leads to the conclusion that phosphorylation of this enzyme is critical to its regulation. Additional studies focus on a substrate of tyrosine kinases in T cells, p120cbl, a proto-oncogene, which may be involved in the Ras pathway in T cells. Earlier studies demonstrate that this protein can be found in a complex with the linker protein Grb2. We have mapped the interaction and have demonstrated that the Grb2-p120cbl complex is regulated by TCR activation. Engagement of the Fc receptor for IgE on mast cells also results in p120cbl tyrosine phosphorylation. In these cells we have demonstrated that the Syk protein tyrosine kinase is primarily responsible for this phosphorylation. Moreover, Syk and p120cbl can be found in a complex whose function is under investigation.